1Florida Alzheimer's Disease Research Center Administrative Core

As a funded P50 center, the current 1Florida ADRC administrative core has successfully
managed the complex multi-institution collaborations vital to our success. We have also garnered
the additional resources and funds needed to accomplish our infrastructure generating and
scientific goals (e.g., funds for additional pilot proposals, ~300 amyloid PET scans, fellowship
support, and data management support) We are adapting our administrative core structure and
personnel to be responsive to the change in funding mechanism, grant structure, and
programmatic goals. These alterations are designed to support i) the highly synergistic
interactions between all the collaborating institutes, ii) an increased emphasis on education and
training, iii) inclusion of developmental projects, and iv) expansions of clinical core activities to
include cohorts at UF and UM. Of particular note, our expanded leadership group positions the
1Florida ADRC well within our institutions to expand Alzheimer ’s disease (AD) and Alzheimer’s
related dementias (AD+ADRD) research activities. This leadership group also provides a breadth
of AD+ADRD reaserch experience and reflects the broad foci of AD+ADRD research across our
institutions. Four Aims are proposed: Aim 1: Provide the vision, infrastructure, oversight, and
overall compliance needed to function as an effective multi-site ADRC. The Administrative core
will coordinate center activities across institutions and track progress towards goals in a milestone
driven fashion. Aim 2. Manage the request for applications, review and award of developmental
projects. Aim 3. Promote AD+ADRD research and educational activities among our collaborating
institutions and throughout the state. Aim 4. Actively leverage resources from our collaborating
institutions, the State, and other stakeholders to advance AD+ADRD research.